U-RISE at Portland State University

The overarching aim of our proposed training program is to provide an integrated experience and pathway for
underrepresented undergraduate students who aspire to become independent biomedical researchers. U-
RISE at PSU will recruit, train, and mentor students from underrepresented groups, using evidence-based
approaches and institutionalizing sustainable programmatic practices. The U-RISE at PSU approach reflects
the following principles: 1) Curriculum must center on inquiry-based learning that fosters scientific thinking and
investigation. 2) Students need authentic long-term experiences contributing to actual research projects and
opportunities to expand and deepen their contributions to research projects over time. 3) Belonging to inclusive
communities, such as peer cohorts and research teams, provides students with a sense of support and identity
as researchers. 4) A team of mentors ensures students have support and guidance in multiple domains
spanning personal, educational, and career development throughout their undergraduate training experience.
5) Students should have opportunities to conceive, propose, conduct, and report on their research with
supportive advising. 6) Students must have a supportive environment addressing their holistic needs for
personal, financial, cultural, social, and educational support. The overall training plan is a comprehensive,
multi-level intervention program that will scaffold several stages of training. The first two stages, Orientation
and Preparation, are designed to recruit a broad group of diverse students who have expressed an interest in
biomedical research, build a supportive peer cohort, and plan for education and career opportunities in
biomedical research. After completing this preparation phase, students apply to become U-RISE trainees,
where they are matched with a Research Learning Community (RLC) and engage in a hands-on long-term
research training experience. The placement phase begins with their first summer research activity, Summer
Induction, provides a guided entry into their RLC. During the Integration stage, U-RISE trainees practice
team science with their RLC team and conduct their own research project during their summer research
Immersion experience. For the culmination phase, RISE trainees continue collaborating in their RLC and
complete the dissemination component of their research. The Culmination phase transitions U-RISE trainees
into a biomedical research-focused graduate program. Throughout U-RISE at PSU trainees will have access to
a multi-tiered mentoring program inclusive of peer mentors, a faculty/career mentor, and a research mentor.
Trainees are required to participate regularly in research enrichment workshops and complete training in
responsible conduct of research and rigor and reproducibility. The intended trainee outcomes include
developing self-efficacy and persistence as a scientist; planning to pursue a biomedical research career;
engaging in experiential learning; presenting at scientific conferences; publishing; graduating; and applying and
being admitted into a graduate program in a field leading to a biomedical research career.

Public health relevance
The proposed scientific training program seeks to address an urgent need: diversifying the biomedical workforce in the United States. U-RISE at PSU will build on our previous experience recruiting, retaining, and training underrepresented students to enter careers in biomedical research. To achieve these goals, we will rely on hands-on learning and research experiences and an integrated and supportive community of mentors, faculty, and peers at Portland State University, which is a diverse urban institution well suited and prepared to conduct this training program.